University of Minnesota Summer Research in Neuroscience

PROJECT DESCRIPTION
Disorders of the nervous system are becoming more prevalent in our society, especially
considering the growing number of people with neurological disorders as our population
ages. To meet the challenge of developing new and effective therapies to treat these
disorders, we need to consistently inspire intelligent and talented undergraduate
students to enter careers in neuroscience research. This need is particularly acute
among populations of students who are currently underrepresented in the field of
neuroscience research. Published analyses have made it clear that making students
aware of research fields early in their college careers, especially by involving them
directly in the research process, is an extremely effective way of developing a student's
interest in research as a future profession. For over 25 years, the University of
Minnesota has recognized and met this challenge by offering summer residential
research programs in biomedical sciences. This proposal is to fund a neuroscience
component of these summer programs in which we will train 8 undergraduate students
who have completed their freshman or sophomore years in college. We will recruit
students nationally, focusing on students from groups that are underrepresented within
the neuroscience research profession. We will provide them with a 10 week intensive
research experience that will include professional mentoring (academic survival skills
and preparation for graduate school) as well as workshops on research ethics. Our
goals are to inspire a new generation of neuroscience researchers as well as to create a
national mentoring pool who will accept that responsibility for future generations of
students. In turn, we expect these individuals to become part of the research
infrastructure dedicated to solving medical problems of nervous system dysfunction.

Public health relevance
PUBLIC HEALTH STATEMENT A major health challenge facing our society is a pervasive range of psychological and neurological disorders, this problem is becoming more acute as our population ages and develops new sets of nervous system disorders. The goal of this project is to support a summer residential research program at the University of Minnesota with the hope of inspiring new generations of bright, talented undergraduate students to enter neuroscience research as a career. The hope is that these future scientists will contribute to the health infrastructure by finding cures for these common, but devastating diseases of the nervous system.